EPR NEWSLETTER

An international EPR newsletter is composed, edited, produced, and distributed to serve the biomedical and EPR research community and disseminate information about the NIH EPR Centers. It is now published quarterly and has grown to close to 140 pages per volume. The Newsletter is distributed to about 4,000 scientists and has been drawing very favorable comments from both American and international colleagues. (In the previous grant year, July of 1996, the International EPR Society presented Dr. Belford and Ms. Gallivan with special awards for their accomplishments in support of the EPR scientific community through this Newsletter.) The editorial through printing operations all are handled by the IERC, with Dr. Belford as Editor, Ms. Rebecca Gallivan as editorial assistant, and Ms. Martha Moore as typist/secretary.